Spatial transcriptomics mapping of basal ganglia to understand critical periods for sensorimotor learning

Summary The basal ganglia comprise key brain structures for generating and refining motor sequences necessary for a variety of complex behaviors that are acquired through procedural learning. These skills are often best learned during early developmental critical periods. Prior work has shown that practicing these skills drives acute changes in gene expression within the underlying basal ganglia microcircuit. This behavior-linked transcriptional activation is observed in juveniles during the sensorimotor critical period but also occurs in adults after the critical period has closed, suggesting that it is not specific to learning. Remarkably, a separate transcriptional profile is only found in juveniles and correlates with the quality of the learned skill. These observations suggest that the spatiotemporal overlap of the behavior-linked and learning-related changes in juveniles constitute a transcriptional program that is permissive for learning. To test this idea, the individual basal ganglia cell types in which these programs occur, currently unknown, must be resolved. Understanding these “transcriptional fingerprints” will be key to deciphering molecular signaling pathways that support sensorimotor learning. This project leverages a well-characterized vertebrate model, the zebra finch, in which basal ganglia transcriptional changes linked to both practice and learning have been demonstrated via bulk sequencing of the entire region, but have not yet been traced to distinct basal ganglia cell types. Thus, one major aim is to identify and compare single-cell gene transcripts from behaviorally activated and non-activated basal ganglia, during and after the critical period, in order to identify specific cell types and cell signaling pathways undergoing behaviorally regulated changes, including those that support learning. In this species, only males undergo sensorimotor learning so comparison to the analogous regions in female brains will highlight the most relevant changes. The second goal is to select key cell type identifiers as well as molecules implicated in the sensorimotor learning process and develop probes to map their spatial expression in samples of the intact microcircuit using multiplexed error-robust fluorescence in situ hybridization (MERFISH). Together, these two integrated aims will illuminate how the basal ganglia changes over the course of repeated behavioral refinement to enable optimal sensorimotor learning. This work has direct implications for better understanding of the mechanisms that underlie the effectiveness of human behavioral therapies and may highlight pharmaco-therapeutic targets to improve treatment efficacy in brain disorders ranging from autism to stroke to cerebral palsy.

Public health relevance
Project Narrative The basal ganglia are key brain structures necessary for refining complex motor patterns in a variety of learned behaviors. Execution of these skills, especially during developmental critical periods, causes gene expression changes that support their learning; however, the changes that are key to this process are entirely unmapped in the basal ganglia microcircuitry. The long-term goal of this proposal is to identify how motor practice including physical and behavioral therapies alter basal ganglia gene expression patterns, which has important implications for remediating sensorimotor impairments in children with neurodevelopmental disorders and in adults following stroke.